Understanding the Development of Mucosal Immunity to Poliovirus: Adjuvants and Modulation of the Enteric Microbiota

Project Summary
Paralytic Polio is a devastating cause of flaccid paralysis, and its eradication is a major initiative of the World
Health Organization (WHO). Eradication requires control of viral shedding and environmental transmission of
poliovirus (PV). Inactivated polio vaccines (IPVs) fail to establish mucosal immunity and viral shedding despite
generating protective antibody responses. Live attenuated oral poliovirus vaccines (OPVs) stimulate mucosal
immunity and limit transmission, but the viral strains used can revert to neurovirulence when shed in the feces
of vaccinees, thus sustaining a viral reservoir for environmental transmission. The candidate will maximize
evaluation of existing data and biospecimens from key clinical PV vaccine-challenge studies using vaccine
shedding as a gold standard assessment of effective antigen-specific mucosal immunity. Through the analyses
described, Dr. Crothers will characterize human immune responses during OPV infection to identify immunologic
target profiles associated with effective mucosal immunity, investigate the relative impact of two modifiable
variables (vaccine priming and the gut microbiota), and evaluate the potential of a novel mucosal adjuvant
(dmLT) to stimulate target immune profiles. This work aligns with the NIAID 2018 strategic plan on vaccine
adjuvants which highlights development of mucosal adjuvants and emphasizes maximizing evaluation of clinical
trial data to enhance our understanding of their mode of action. Through this K23 Mentored Clinical Scientist
Research Career Development Award, Dr. Crothers will pursue advanced training in clinical research and
computational techniques with a focus on data integration across clinical trials and data types. This work will
build on the candidate’s background of doctoral research training in immunology and microbiology and build new
skills in microbiome data analysis, bioinformatics, and novel computational approaches through formal
coursework and practical application. Situated in the stimulating environment of her primary mentor (Dr. B.
Kirkpatrick) at the University of Vermont Translational Global Infectious Diseases Research Group and Vaccine
Testing Center with easy access to the research groups of her co-mentor (Dr. P. Wright) and key advisor (Dr. A.
Hoen) at Dartmouth College, her work will be guided by a team of experts in poliovirus immunology,
computational methodologies, and translational research. This work will position the candidate to launch her
career as an independent physician scientist at the intersection of enteric infectious diseases and mucosal
immunology with a focus on harnessing the clinical potential of the human microbiome to prevent and treat
enteric diseases.

Public health relevance
Project Narrative Critical to polio eradication efforts is development of new vaccines that stimulate effective mucosal immunity in the gut to control viral shedding and eliminate environmental reservoirs of poliovirus (PV). This project will provide critical information to better understand the immunologic and microbiologic factors impacting development of effective mucosal immunity to PV. It will also assess the effect of a novel mucosal adjuvant (dmLT) on systemic and mucosal immune responses to Inactivated Poliovirus Vaccines (IPV). The goal of these investigations is to guide future studies directed at harnessing immune-microbiota interactions to enhance mucosal immune responses to polio vaccines and other enteric pathogens.